Effects of State Laws to Reduce Opioid Diversion on Transitions to Injection Drug Use and HIV/HCV Transmission

The purpose of the proposed R01 project entitled “Effects of State Laws to Reduce Opioid Diversion on
Transitions to Injection Drug Use and HIV/HCV Transmission” is to examine the effects of state laws designed
to reduce opioid diversion and misuse on the transition to injection drug use and HIV/HCV infection. These
laws vary in content and implementation by state and include state prescription drug monitoring programs
(PDMPs), Medicaid policies that may decrease access to prescription opioids such as prior authorization or
pharmacy lock-in programs, Medicaid reimbursement of Medication Assisted therapy, and state regulations of
pain clinics. The proposed research will explore the influence of laws in three different states, Connecticut,
Kentucky and Wisconsin, selected to represent differences in PDMPs, Medicaid restrictions on opioid
prescription, and pain clinic regulation. We will also examine the effects of the local context (drug use
networks, syringe availability, harm reduction services, relative price and quality of heroin) on the transition to
injecting non-prescription opioids and /or heroin injection in three local areas, an urban area, a smaller
metropolitan area or suburb, and a rural town and surrounding county, chosen to reflect areas with higher rates
of opioid prescription and opioid overdoses. Specific aims include the following: 1) Identify state laws and
policies that have been established to decrease opioid misuse and diversion to establish or refute their
association with transition to opioid or heroin injection; 2) Identify how local implementation of state laws and
policies may contribute to the transition from nonmedical prescription opioid use to injecting prescription
opioids or injecting heroin; 3) Compare local factors in urban, suburban and rural areas that affect the riskiness
of injection practices such as the availability of clean syringes, density of drug using networks and accessibility
of drug treatment programs. The proposed research will use a two-phase (formative and hypothesis testing)
mixed methods design comparing the three states and local areas (3 per state, n=9) to examine factors
affecting the relationship between prescription opioid laws and policies and the transition to opioid or heroin
injection.
.

Public health relevance
In response to rising rates of opioid dependence and fatal poisonings, virtually every US state has incorporated laws to reduce the availability of medical opioids for diversion. However, little research has examined the effects of these laws on the transition to injecting opioids or heroin. To our knowledge, the proposed research is the only study to date that will examine the effects of state laws and policies on transition to injection of prescription opioids or heroin. This will allow us to identify multiple points of intervention at the policy level in ways that will maximize benefits and minimize potential harms, and adapting harm reduction services to new contexts.